ADalimimab Vs conventional ImmunoSupprEssion for uveitis (ADVISE) Trial

Program Director/Principal Investigator (Last, First, Middle): Altaweel, Michael M.
PROJECT SUMMARY
The uveitides are a collection of diseases characterized by intraocular inflammation. Collectively, they are the
5th leading cause of blindness in the US, and the estimated cost of treating them is similar to that of treating
diabetic retinopathy. Non-infectious intermediate, posterior, and panuveitides have the highest rates of visual
loss and typically are treated with oral corticosteroids and immunosuppression. The Multicenter Uveitis Steroid
Treatment (MUST) Trial (a randomized, comparative effectiveness trial, which compared 2 treatment
paradigms for these diseases, systemic therapy with corticosteroids and immunosuppression vs. regional
therapy [the fluocinolone acetonide implant]), and Follow-up Study demonstrated the superiority of the
systemic approach to the regional ocular approach in terms of long-term visual outcomes with essentially no
increase in systemic side effects in the systemic group. One key to systemic therapy's success was the use of
systemic immunosuppression in 88% of participants, coupled with tapering the prednisone to <7.5 mg/day, a
relatively safe dose. The drugs used most often used are azathioprine, methotrexate, mycophenolate,
cyclosporine, and tacrolimus. The alkylating agents, cyclophosphamide and chlorambucil, are used less often
because of concerns about potential increased malignancy risk. Available data suggest that single-agent
conventional, non-alkylating-agent, immunosuppressive drugs are effective in controlling the inflammation
while permitting tapering prednisone to <10 mg/day in ~40-55% of patients; hence, combination therapy often
is needed. Minimizing the daily dose of prednisone is important, as the risk of cardiovascular disease and
mortality increases with the cumulative dose of oral corticosteroids. In June 2016, the fully-human, anti-TNF-α
monoclonal antibody, adalimumab, was approved by the US Food and Drug Administration (FDA) for the
treatment of uveitis. Anti-TNF-α monoclonal antibody therapy has revolutionized the management of the
rheumatic diseases largely due to its superior efficacy compared to conventional Disease Modifying Anti-
Rheumatic Drugs. Data from VISUAL III, the extension of the two phase 3 trials that led to the FDA approval of
adalimumab for the treatment of uveitis, suggest that adalimumab may be superior to conventional
immunosuppression, as ~75% of participants had controlled inflammation with prednisone doses <5 mg/day
sustained through 1 year of follow-up. The ADalimumab Vs. conventional ImmunoSupprEssion for uveitis
(ADVISE) Trial is a randomized, comparative effectiveness trial comparing adalimumab to conventional agent
immunosuppression for patients with non-infectious, intermediate, posterior, and panuveitides. The primary
outcome is the ability to successfully taper prednisone to <7.5 mg/day by 6 months after randomization while
maintaining control of the inflammation. Secondary outcomes include prednisone discontinuation with
inflammation control by 1 year, visual acuity, and incident complications of uveitis and its treatment.
OMB No. 0925-0001/0002 (Rev. 08/12 Approved Through 8/31/2015) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Altaweel, Michael M. PROJECT NARRATIVE Non-infectious intermediate, posterior, and panuveitides are chronic, potentially-blinding diseases; vision- threatening cases typically require long-term therapy with oral corticosteroids and immunosuppression. Based upon preliminary data adalimumab, a fully-human, anti-TNF-α monoclonal antibody, now US FDA-approved for uveitis treatment, may be a superior corticosteroid-sparing agent to conventional immunosuppressive drugs. The ADVISE Trial is a randomized, comparative effectiveness trial of adalimumab vs. conventional immunosuppression for the treatment of non-infectious intermediate, posterior, and panuveitides. OMB No. 0925-0001/0002 (Rev. 08/12 Approved Through 8/31/2015) Page Continuation Format Page